Caregiver Education with Interactive Neurodevelopmental Games to Improve Cognitive and Social-Emotional Outcomes in Infants Undergoing Treatment for Medulloblastoma

PROJECT SUMMARY/ABSTRACT
Childhood brain tumor survivors are at significant risk for cognitive and social-emotional difficulties, which are
associated with reduced quality of life. With a growing survivor population, efforts to offset the burden survivors
endure following life-saving treatments are imperative. Nearly half of all childhood cancer diagnoses occur in
children under 5 years of age. Young age at diagnosis is the most consistent risk factor for cognitive late
effects due to a rapidly developing brain, and disruption to the early learning environment. Medulloblastoma is
the most common metastatic brain tumor in infants, with aggressive and lengthy treatment required for cure. A
primary goal of this research program is development of interventions that mitigate the impact of cancer and
cancer therapies on cognitive outcomes of childhood cancer survivors. Current interventions exclusively target
children 4 years and older, despite extensive evidence that influencing early cognitive development has the
potential for significant clinical impact. A caregiver educational program (CEP) has been designed to improve
understanding of the importance of the early learning environment on child brain development. This CEP can
be combined with a set of interactive neurodevelopmental games (INDG) designed for parents to play with
their children to strengthen brain pathways for specific skills, at times when each brain pathway is particularly
sensitive to life experiences. Studies have shown this CEP+INDG is effective in teaching key developmental
neuroscience concepts to caregivers, with significant associated improvement in parent-child interactions and
child problem-solving skills. Families of infants with brain tumors are an ideal target for CEP+INDG given these
children are highly vulnerable, have no research supported intervention options, and evidence for intervention
efficacy. There have been no studies investigating either intervention in children undergoing cancer treatment.
Accordingly, the specific aims of this study are: 1) To evaluate the feasibility and acceptability of CEP+INDG
(i.e., enrollment, completion and satisfaction rates) in infants undergoing medulloblastoma treatment; 2) To
estimate the magnitude of change in caregiver-child interactions (connection and reciprocity using validated
behavioral coding) following intervention; and 3) To estimate the magnitude of change in cognition and social-
emotional development associated with intervention. We propose a single-blind (examiner), randomized
controlled trial for infants (0-36 months) undergoing medulloblastoma treatment. Participants will be
randomized (2:1) to CEP+INDG or standard of care (SOC). One to two months after initiating chemotherapy,
caregivers in the intervention group will participate in a tailored 60 minute CEP. They will then receive 30 text
prompts over a 3 month period to access INDG on their phone; age appropriate games are selected that can
be completed in any setting. INDG records frequency and timing of game access. Both groups will complete
pre- and post-intervention/SOC assessments of caregiver-child interactions and child development. We will
recruit until 40 dyads have completed post assessments. Study results will inform a larger randomized trial.

Public health relevance
PROJECT NARRATIVE Relevance Nearly half of all childhood cancers occur in children under 5 years of age who are at greatest cognitive risk due to a rapidly developing brain and treatment-related disruption to the early learning environment; yet, there are no studies of cognitive interventions targeting young children undergoing cancer treatment. Studies have shown caregiver education regarding the importance of the early learning environment on child brain development combined with interactive neurodevelopmental games designed to strengthen brain pathways for specific skills, at times when the pathways are particularly sensitive to life experiences, are associated with improvement in parent-child interactions and child problem solving skills. If caregiver education combined with interactive neurodevelopmental games are shown to promote cognitive and social-emotional development in infants undergoing medulloblastoma treatment, there is great potential for reducing cognitive morbidity and improving quality of life for the entire population of young children undergoing cancer therapy.